SAFETY AND EFFICACY OF GM-CSF IN RESISTANT MALIGNANCIES

To determine the effectiveness, optimal dose, and side effects of recombinant human granulocyte-macrophage colony stimulating factor given as supportive care to patients receiving a combination of cyclophosphamide, VP-16, and cisplatinum in high doses in patients with advanced malignant disease which has not responded to treatment.